DENTAL RESEARCH INSTITUTE SUPPORT

1. To provide a multidisciplinary effort for the study of a) Periodontal disease; b) Dental caries; and 2. To participate in the training of individuals who will continue in research relevant to dentistry, thereby augmenting the manpower pool for the delivery of oral health care.